REVERSAL OF COR PULMONALE AND RIGHT VENTRICULAR HYPERTROPHY WITH NOCTURNAL O2

Patients with chronic lung disease are known to frequently exhibit arterial oxygen (O2) desaturation during sleep, despite adequate daytime saturation. Nocturnal desaturation may result in sleep fragmentation, pulmonary hypertension & right heart dysfunction. This study proposes to assess the effect of nocturnal O2 therapy on sleep quality, pulmonary hypertension and right ventricular function.